Diversity Supplement (Monica Quinones-Frias): Roles of Recycling Endosomes in Neuronal Extracellular Vesicle Cargo Traffic

PROJECT SUMMARY
The goal of this proposal is to understand how cellular membrane trafficking machinery controls the
packaging and release of extracellular vesicle (EV) cargoes from synapses in vivo. EVs are small
membrane-bound vesicles released by numerous cell types including neurons, carrying cargoes critical for
signaling and disease. However, we understand very little about how EV cargo traffic is spatially and
temporally regulated within the polarized and complex morphology of neurons. We have developed tools to
track and manipulate EV traffic at Drosophila presynaptic terminals in vivo, and discovered that flux of
cargoes through a plasma membrane-recycling endosome route determines whether they are locally sorted
for packaging and release in EVs, rather than depleted from synapses by retrograde transport. Recycling
endosomes have primarily been studied in non-neuronal cells, and very little is known about their lifetime,
functions, or dynamics at presynaptic terminals. We do know that recycling endosomes play critical roles in
signaling, neuronal morphogenesis, EV traffic, and synaptic transmission. Understanding and
therapeutically intervening in these important processes will require a deeper knowledge of the mechanisms
of neuronal recycling endosome function. In this proposal, we will elucidate the mechanisms of synaptic EV
cargo and recycling endosome traffic in vivo. To achieve these goals, we will use Drosophila genetics,
biochemistry, high-resolution microscopy, and live cell imaging. 1) We will determine the functions,
dynamics, and regulation of different types of synaptic recycling endosomes. To this end, we will develop
new tools and approaches to define and control functionally distinct recycling compartments at synapses.
Using these tools, we will test novel mechanistic hypotheses for how membrane traffic machinery sorts
cargoes at synaptic recycling compartments. 2) We will determine how EV cargo traffic depends on distinct
modes of synaptic endocytosis: clathrin-mediated endocytosis, which operates under low neuronal activity
and activity-dependent bulk endocytosis, which operates during intense neuronal activity. These
experiments will ascertain if EV fate is determined by different modes of internalization, how recycling
endosomes contribute to these functions, and provide new mechanisms to link activity, endosomal traffic,
and EV release. Given the conserved nature of synaptic membrane trafficking machinery, our findings and
tools will lay the foundation for new insights into EV traffic in many aspects of nervous system function,
including in human neurological disease.

Public health relevance
PROJECT NARRATIVE Neurons can communicate with each other via electrical and chemical signals, as well as membrane-bound packets called extracellular vesicles. These vesicles carry cargo that can contribute to normal brain function, but in neurological disorders including Parkinson’s and Alzheimer’s Diseases, they can also spread toxic proteins throughout the brain. Our research will help us understand how extracellular vesicles are packaged, released and spread in the nervous system, and may identify new strategies to treat a wide variety of neurological diseases.